Acute effects of THC in older adults

ABSTRACT
Background: The use of cannabis is growing in older adults but there is very limited high quality
information on the acute effects of cannabinoids in healthy older adults. As the legalization of cannabis
continues to increase globally, the age range of individuals using cannabis across the lifespan continues to
expand, and the aging population continues to increase. Recent statistics indicate an increase in recreational
cannabis use by 75% and higher use of medical cannabis in older adults compared to younger adults3,4. As the
baby boomer generation grows older and the legal status of cannabis changes globally, the use of cannabis by
older individuals is projected to continue to grow5. The acute effects of cannabis in older individuals could be
different due to important age-related cognitive and physiological differences. First, the target of THC, the
endocannabinoid (eCB) system, changes across the lifespan. Second, age-related reductions in cognitive
reserve could make older adults more susceptible to the cognitive-impairing effects of cannabinoids. Third, the
aging brain may be less reward-driven6. Fourth, given the cardiovascular risks of cannabinoids7, age-related
reductions in cardiovascular reserve could place older adults at greater cardiovascular risk. Finally, age-related
changes in metabolism8 could impact the response to cannabinoids.
Hypotheses: Increasing age will confer greater vulnerability to THC-induced cognitive impairments, anxiogenic
effects, and cardiovascular effects but are less vulnerability to its rewarding effects. Increasing age will confer
greater vulnerability to THC-induced deficits in electrophysiological indices of information processing including.
Pilot data: Older (>50 years old, n = 4) adults are more vulnerable to the acute memory-impairing and anxiogenic
effects of THC than younger adults (<25 years, n = 5).
Methods: In this double-blind, placebo-controlled, hybrid fixed-order/randomized, single test day laboratory
study 60 adults ( 21 years) will receive 0 (placebo) and 0.03 mg/kg of intravenous THC over 20 minutes.
Cognitive function (memory, attention, etc.) and proximal measures of attention and information processing (EEG
measures, including P300, ASSR, and neural noise) will be tested after the administration of THC/placebo.
Subjective effects, perceptual alterations, vital signs, objective measures of information processing (EEG), and
blood for PK will be collected before and after the administration of THC.

Public health relevance
PROJECT NARRATIVE Cannabis use is rapidly growing in older adults, but there is no reliable experimental data about the acute effects of cannabinoids in healthy older adults. In this double-blind, placebo-controlled study, the impact of age on THC effects will be investigated.